Laboratory Services Section, Department of Transfusion Medicine Core Report

This Core Report summarizes the publications from the Laboratory Services Section (LSS) of the Department of Transfusion Medicine (DTM) in the NIH Clinical Center. All reports are included, which were published since 2019 by LSS, as long as they are not covered in other NIDB reports from LSS. The list comprises collaborations with NIH Institutes, the FDA, and national non-government institutions as well as international institutions. The list includes original research contributions, committee reports, reviews, commentaries, and editorials, along with studies supported by transfusion medicine resources within LSS.